University of Miami IBD Genetic Research Center: Understanding the Genetic Architecture of IBD in the South Florida community

PROJECT SUMMARY
Inflammatory bowel disease (IBD) is a common and devastating immune-mediated disease in which the
mucosal immune system abnormally recognizes the intestinal bacterial flora leading to chronic inflammation.
Approximately, 1% of the US population is affected. The causes of Crohn's disease (CD) and ulcerative colitis
(UC) lie in the interplay between host response genes and a microbiome with pathogenic properties. IBD
incidence has leveled off in the developed world and rising in the newly industrialized world. In the US, we are
witnessing a rising incidence in immigrants from low-risk parts of the world, particularly Hispanics. This provides
an opportunity for discovery of disease pathogenesis towards a goal of prevention and improved therapies.
Our group has a dedicated research interest on IBD in Latin-American immigrants and American-born
Hispanic patients. We have published highly-cited studies of the genotype and phenotype of IBD in the Hispanic
population of South Florida. We have also described disparities in medication usage and surgical rates. Important
for the notion that IBD is caused by a gene-environment interaction, we have found that IBD is occurring faster
in the last 20 years in immigrants from Latin-America. Miami-Dade County is over 50% Hispanic, and Florida
has the 3rd largest Hispanic population with the most diverse countries of origin representation.
To enhance our research capabilities, we are requesting supplemental funding to add a new research
coordinator focused on improving participant engagement, recruitment, and retention, particularly among
Hispanic communities in South Florida. This coordinator will receive comprehensive training in culturally
competent recruitment strategies and research coordination. While the parent project has made significant
progress, the addition of this coordinator will enable us to open four new recruitment sites and increase overall
study participation, addressing social barriers faced by Hispanic IBD patients.
Our research will explore genetic variation in a large set of US-born and foreign-born Hispanic IBD cases by
focusing on targeted genomic, transcriptomic, and epigenetic differences between immigrant and first-generation
Hispanic-Americans with IBD. We will investigate how genes and environment interact to result in diverse
phenotypic manifestations of IBD. Our group has particular expertise in fine-mapping previously identified risk
loci and assessing the impact of local genetic ancestry on genotype-ancestry interactions in relation to
phenotypic characteristics. These studies will expand knowledge of disease phenotype and genetic
underpinnings in IBD in this growing Hispanic cohort, with the goal of developing prevention and improved
treatment approaches.

Public health relevance
PROJECT NARRATIVE Inflammatory bowel diseases (IBD) are immune-mediated diseases whose downstream consequences include surgery and cancer, leading to medical disability and a high economic and social burden in the US. Although traditionally thought of as a disease affecting primarily individuals of European descent, a rising number of Hispanics, both foreign-born and first-generation Hispanic-Americans, are developing IBD. This supplement will enhance the capacity and effectiveness of our existing parent grant by supporting an additional research study coordinator who will focus specifically on strengthening participant engagement, recruitment, and retention efforts among communities within and across South Florida in support of our study enrollment goals.